Eradication of clonally expanded CD4+ T cells

Project Summary
Clonal expansion is a process where latently infected CD4+ T cells proliferate in
response to their cognate antigen. It is thought that this process contributes significantly
to the size of the HIV reservoir and therefore disrupting this mechanism could have a
huge impact on the number of latently infected cells. We observed a significant decline
in the number of expanded CD4+ T cell clones in an elite suppressor who received
chemoradiation for lung cancer and we hypothesize that we can recapitulate this in vitro
by stimulating CD4+ T cells with a combination of cognate antigen to induce
proliferation, and either chemotherapeutic or antiproliferative agents that would
selectively kill the dividing antigen-specific CD4+ T cells. If successful, a two-step
process of vaccination of individuals with cognate antigen and short term treatment with
chemotherapeutic or antiproliferative agents may be part of a strategy to reduce the size
of the reservoir.

Public health relevance
Project Narrative Clonally expanded CD4+ T cells contribute significantly to the HIV reservoir. These cells are driven by proliferation in response to common viral antigens. We hope to use a combination of stimulation with these antigens and chemotherapeutic or antiproliferative drugs to selectively deplete these clonally expanded cells.